Breast Oncology Program

Breast Oncology Program: Summary
The mission of the Breast Oncology (BR) Program is to develop innovative approaches to describe the
molecular and cellular networks underlying breast cancer susceptibility, heterogeneity, diversity, and disparities
with the aim of improving outcomes for healthy women and women with breast cancer. The BR Program's
work aims to reduce overdiagnosis and overtreatment through individualizing screening and treatment, and
derive better outcomes at lower cost. The BR Program achieves its goals through four themes:
Theme 1: Improving the Understanding of Breast Cancer Etiology in the Context of the Microenvironment
Theme 2: Personalizing Screening and Diagnostics to Increase Health Care Value
Theme 3: Identifying New Therapeutic Targets for High-risk Disease
Theme 4: Augmenting Efficiency of Drug Development through Innovative Trial Design
BR Program: Key Metrics
Membership (14 departments, 3 schools) 33
Full 18
Associate 15
Cancer-relevant Funding (direct costs as of
$14,454,243
05/31/2017)
NCI $5,307,970 37%
Peer-reviewed $4,630,302 32%
Non-peer-reviewed $4,515,971 31%
Cancer-relevant Publications (1/2012-7/2017) 636
Inter-programmatic 141 22%
Intra-Programmatic 175 28%
High-Impact 190 30%
Accruals to Clinical Trials (2016) 5293 58
Therapeutic 140 31
Other Interventional 9 4
Non-interventional 5144 22